OVEREXPRESSION OF APP AND CEREBROVASCULAR REGULATION

DESCRIPTION (provided by applicant): Alzheimer's disease (AD) is the leading cause of dementia, and there is a pressing need to develop treatments to mitigate its enormous human and public health impact. Amyloid-β (Aβ) is a key pathogenic factor in AD, but its mechanisms of action are not well understood. In addition to damaging neurons and glia, Aβ also impairs vital neurovascular mechanisms that regulate the cerebral blood supply, thus increasing the brain's susceptibility to hypoxic-ischemic injury. Vascular dysfunction may also compromise brain Aβ clearance, promoting the retention of the peptide and its damaging effects. During the previous funding period we have established that Aβ exerts its deleterious vascular effects by engaging the Aβ-binding scavenger receptor CD36. CD36, in turn, leads to the production of reactive oxygen species (ROS) by activating Nox2. However, the cells expressing CD36 on which brain Aβ acts on the abluminal side of cerebral blood vessels to increase Nox2-dependent ROS production remain unknown and their elucidation may suggest novel targets for AD therapy. Resident brain macrophages, mainly perivascular macrophages (PVM), reside along the Aβ clearance pathway, express CD36 and Nox2, and are in close contact with the outer vessel wall. Therefore, PVM are uniquely positioned to contribute to vascular oxidative stress and neurovascular dysfunction induced by brain Aβ. The central hypothesis of this application is that CD36 in PVM participates in the deleterious vascular effects of Aβ and in the long-term consequences of Aβ overproduction. We will test the following specific hypotheses: (1) PVM are the cells on which brain Aβ acts to induce vascular oxidative stress and dysfunction; (2) CD36 in PVM is responsible for these actions of Aβ, and (3) CD36 in PVM contributes to the long-term consequences of Aβ overproduction, including cognitive deficits and perivascular Aβ accumulation. Our studies will use state-of-the-art methods to investigate neurovascular regulation in mice. Pharmacological approaches and bone marrow chimeras will be used to investigate the specific role of CD36 in PVM in Aβ-induced oxidative stress, neurovascular dysfunction, and cognitive deficits. PUBLIC HEALTH RELEVANCE: There is an urgent need to develop treatments for Alzheimer's disease (AD), the most common cause of dementia. We propose to investigate how the Aβ peptide, a key pathogenic factor in AD, damages cerebral blood vessels and contributes to the brain dysfunction underlying the dementia. We will focus on the role of perivascular macrophages and on the scavenger receptor CD36. The proposed studies may establish CD36 on perivascular macrophages as a new therapeutic target to counter the deleterious vascular effects of Aβ on the brain.

Public health relevance
There is an urgent need to develop treatments for Alzheimer's disease (AD), the most common cause of dementia. We propose to investigate how the Aβ peptide, a key pathogenic factor in AD, damages cerebral blood vessels and contributes to the brain dysfunction underlying the dementia. We will focus on the role of perivascular macrophages and on the scavenger receptor CD36. The proposed studies may establish CD36 on perivascular macrophages as a new therapeutic target to counter the deleterious vascular effects of Aβ on the brain.